Hyperbaric Oxygen Brain Injury Treatment (HOBIT) Trial - CCC

There continues to be an overarching problem of high mortality and poor outcome for
victims of severe traumatic brain injury (TBI). Preclinical and clinical investigations indicate that
hyperbaric oxygen (HBO2) has a positive impact on reducing brain injury and improving
outcomes in severe TBI. By markedly increasing oxygen (O2) delivery to the traumatized brain,
HBO2 can reverse the lack of O2 that precipitates cellular energy failure and subsequent brain
cell death. In past clinical investigations, HBO2 in comparison to standard care has significantly
improved energy production in the brain and improved clinical outcome. However, prior to a
formal phase III definitive efficacy study, important information is required regarding optimizing
the HBO2 treatment schedule to be instituted in terms of pressure and frequency and other
parameters. The lungs in severe TBI patients have frequently been compromised by direct lung
injury and/or acquired ventilator pneumonia and are susceptible to O2 toxicity. It is essential to
determine the most effective HBO2 dose schedule without producing O2 toxicity and clinical
complications. This proposed adaptive clinical trial is designed to answer these questions and
to provide important data to plan a definitive phase III efficacy trial.
Primary aims of this trial are to select, in patients with severe TBI, the combination of
HBO2 treatment parameters that is most likely to demonstrate improvement in the outcome of
severe TBI patients in a subsequent phase III trial. Also the trial will determine, in patients with
severe TBI, whether there is a > 50% probability of HBO2 treatment demonstrating
improvement in the outcome of severe TBI in a subsequent confirmatory phase III trial.
This trial is supported and sponsored by the Neurological Emergency Treatment Trial
(NETT) Network which is funded by the National Institutes of Neurologic Disease and Stroke to
conduct clinical trials such as the one described. The NETT helps ensure a well-planned and
well-conducted clinical trial.

Public health relevance
The human and economic consequences of severe TBI are enormous. Despite approximately 30 clinical trials evaluating various treatments for severe TBI, a specific treatment has been elusive. Hyperbaric oxygen provides one of the best opportunities for demonstrating a specific treatment for severe TBI. If successful, the human and economic benefits to society worldwide would be great.